A Mixed-Method Study on Transgender and Gender Diverse Adults’ Alcohol Use

Project Summary/Abstract
Transgender and gender diverse (TGD) adults are at greater risk for alcohol use, alcohol-related problems, and alcohol use
disorders relative to cisgender adults. Thus, having culturally-competent alcohol use assessments and interventions that
effectively target salient risks within this population is critical from a public health perspective. Yet, despite increased
attention on this vulnerable population, extant theory concerning alcohol risk and resilience within TGD populations
suffers from numerous theoretical and methodological limitations. This includes (a) a narrow perspective of risk that fails
to consider the incremental validity of different stressors facing TGD adults, (b) the operationalization of risk within
racially homogeneous, White samples that may not capture risks and strengths relevant in racially, ethnically, and
sexually diverse samples, and (c) reliance on quantitative approaches that fail to facilitate the translation of indices of
alcohol use within TGD communities into clinical protocols. Addressing these limitations is the answer to laying the
foundation for more culturally affirming and clinically useful models for explaining and intervening with alcohol use in
TGD populations. Our study is consistent with NOT-MD-19-001, “Notice of Special Interest in Research on the
Health of Sexual and Gender Minority (SGM) Populations.”
The proposed study seeks to address these aims via a novel, mixed method research approach. In the first phase of the
study, we will conduct secondary data analyses on a large, diverse sample of TGD adults (N=27,715; U.S. Transgender
Survey) to examine which minority stress experiences in the empirical literature are robust predictors of alcohol use
across gender identities (e.g., non-binary, trans men, trans women) and intersecting identities (e.g., race, ethnicity, sexual
orientation). Our analytic plan will use a multi-level modeling approach (i.e., MAIHDA models) to better capture the
influence of intersecting identities on risk, as well as an evidence-based medicine (EBM) approach to demonstrate the
clinical utility and statistical fairness of an alcohol use risk algorithm informed by minority stress theory for TGD adults.
In the second phase of the study, qualitative interviews will be conducted with 60 TGD, drinking adults, to gain
perspectives on top-down minority stress theories tested in Phase I, as well as other salient risks, needs, and strengths
missing from current conceptualizations of alcohol use within the TGD community. The sample will be stratified by
gender identity, race, and ethnicity to ensure a representative perspective on the environmental events and dynamic
processes most salient to TGD adults’ perspectives on problematic alcohol use. Collective findings from our study will
inform an R34 application that focuses on developing a TGD-affirming alcohol intervention.

Public health relevance
Project Narrative The proposed mixed method study leverages the unique strengths of secondary data analyses and qualitative interviews to lay the foundation for a more culturally-competent and clinically useful approach to understand risk and resilience for alcohol use in transgender and gender diverse (TGD) adults. Findings from our study will highlight the dynamic risks, strengths, and needs related to alcohol use that comprehensive clinical protocols should target when working with diverse TGD populations.